RECURRENT GALLSTONE DISEASE AND CHOLEDOCHOLITHIASIS

These studies are designed to define alterations in biliary lipid metabolism in patients with choledocholithiasis, cholesterol synthesis, cholesterol absorption, biliary lipids and bile acid synthesis are measured.